CLINICAL INVESTIGATIONS AND CASE REPORTS

Clinical case studies of unusual interest and clinically related research are being conducted on a variety of dentally related subjects. Research techniques being utilized include chart and literature reviews and evaluation of various therapeutic regimens.